Michigan-Unijos Mentored Program for Enhanced Research Administration (MUMPERA)

Project Summary
The US government is the world’s largest bilateral funder of health sector interventions in dollar terms. The
USA’s funding for HPSR was provided through its various agencies with a remit on global health, like the
National Institutes of Health, the Centres for Disease Control and the US Agency for International
Development. To further support this position, the University of Jos/Jos University Teaching Hospital has
received 80% of its funding from the US Government, from the U.S. President’s Emergency Plan for AIDS
Relief (PEPFAR), to the National Institutes of Health (NIH), Center for Disease Control (CDC), Bill and
Melinda Gates Foundation, Carnegie Foundation of New York, Families and Foundations that have
sponsored Cancer Researches.
It is therefore, imperative, to constantly, understand the funding requirements, guidelines for applications and
grants management systems for these US agencies, with particular attention to the National Institute of
Allergy and Infectious Disease (NIAID) and the National Institutes of Health (NIH), as an agency. The
University of Jos/Jos University Teaching Hospital, grant application has increased with 30% over the last 2
years, and the funding from the NIAID, has also increased, though as sub-contracts. Quite a number of
policies for Systems of Award Management (SAM.Gov), eRA Commons, Payment Management Systems
(PMS), Grants.gov, login.gov, NCAGE and dynamic institutes changes in funding guidelines, has occurred
in the last 2 years and are still changing. If Research Administrators and Finance Managers of NIH projects
do not keep abreast of these changes, it will affect their respective institutions’ chances of seeking and
managing funded projects.
Through this project, the University of Jos/Jos University Teaching Hospital will build on the successes of
trainings and business tools instituted in the phase 1 of the project, to develop train new/junior administrators
for the NIAID supported West Africa Center for Emerging Infectious Diseases (WACEID) and other partner
institutions with NIAID/NIH projects in Nigeria and West Africa; other administrators in the departments,
faculties (schools and colleges), centers and institutes in UniJos/JUTH to manage NIH and other funded
projects. The MUMPERA project will also work with the University of Michigan Office of Research and
Sponsored Programs Staff, to conduct training for two administrators, and other administrators in
Nigeria/West Africa. The partnership will also support the development of an electronic system for grant
submission and management as well as develop online and web resources, to support grants administration
and grantsmanship in the UniJos/JUTH during the project sustainability period.

Public health relevance
Project Narrative Global Infectious Disease Research Administration Develop Program for Low-and-Middle-Income Countries is an intervention to increase the capacity of Research Administrators and Finance Managers of NIAID/NIH projects to support the mission of the institute in ameliorating infectious diseases in the world. This investment by the institute has rippling positive effects, on not only the prime institution, but also other local in-country institutions as well as regional institutions; through this, information of funding opportunities for health research, establishing grant management offices, and strengthening existing ones, has been implemented. It has brought great awareness to the business of grants administration, among Faculty Researchers, and institution management support for new policies and procedures for the implementation of external funding; it has also impacted on internal funding operations, for global health or social researches, by other international or local funders.